Real-time Infection Prediction in Inpatient Postoperative Care

Postoperative infections are the most common surgical complication, affecting upwards of 40 Veterans each day
and adding an estimated $25,000 to the total cost of care per infection. More than half of all postoperative SSIs
are diagnosed after the patient has been discharged from the hospital. Current decision support tools for
postoperative infections suffer from poor predictive accuracy. This makes it particularly hard to identify patients
at risk for developing an SSI after hospital discharge which complicates discharge planning. Accurately
identifying patients with a high risk of infection at discharge could help to improve discharge planning, identify
adequate timing for post-discharge follow up, and better target resource-expensive post-discharge surveillance.
Vital signs, such as temperature or pain, have consistently been shown to predict infections. They are routinely
collected during inpatient stays but have remained an untapped source of information for infection risk prediction
models. We hypothesize that we can improve the accuracy of existing infection risk prediction models
by including this real-time vital sign data. While planning our larger study, we have identified several feasibility
concerns that should be addressed before we embark on developing the tool and testing it in a clinical
environment. Thus, we are seeking HSR&D Pilot funding to finalize the protocol of our planned HSR&D
Investigator-Initiated Research study.
Our study aims are as follows:
1. Perform a developmental formative evaluation assessing the feasibility, acceptability, potential usefulness
and initial design of a decision support tool for predicting infection risk at discharge.
2. Examine the completeness of inpatient vital sign data collected in the VA Corporate Data Warehouse.
We have planned our study using a person-centric design thinking framework. For aim 1, we will use qualitative
methods to analyze data from 20 structured observations at two VA facilities and 15 semi-structured interviews
across at least six VA facilities. These qualitative analyses will verify that our proposed tool can be incorporated
into clinical care at the VA, that clinical providers will accept the tool, and that it will be perceived as useful. We
will also begin to develop an initial prototype for the tool’s user interface and deployment within VA clinical care.
Aim 2 addresses a feasibility concern about building our model with potentially incomplete vital sign data. The
VA Corporate Data Warehouse (CDW) is the standard location for accessing inpatient vital signs collected across
the entire VA. Unfortunately, we have discovered that not all local vital sign data make it into the CDW and some
vital sign data are only captured in VISN-specific databases. This leads us to concerns about the impact of
missing data when using national CDW data to refine existing models with vital sign data. For aim 2, we will use
quantitative methods to analyze an existing database of all patients admitted to six VA facilities in VISN 21. To
confirm the feasibility of developing our model and tool prototype, we plan to determine how all vital signs are
captured in the VA, examine the completeness of the vital sign data, and explore the impact and potential biases
of using incomplete CDW vital sign data. The findings of aim 2 will determine strategies for developing the tool
at VA Palo Alto Health Care System and expanding the tool across other facilities and VISNs.
Updating current infection risk prediction scores with vital sign data has the potential to greatly increase the
accuracy of risk prediction for postoperative infection. A more accurate prediction of high-risk patients at the time
of discharge will improve discharge planning and help providers identify high-risk patients that would benefit from
earlier postoperative follow-up. It could also help better allocate other resource-intensive and expensive
preventative strategies such as prophylactic antibiotics or negative pressure wound therapy. This would result
in substantial reductions in costs, morbidity, and mortality. Also, this study will inform the VA research community
on the availability and use of vital sign data stored within the VA.

Public health relevance
Postoperative infections are prevalent, affecting up to 40 Veterans each day, and costly, adding upwards of $25,000 per infection to healthcare costs. They are the most common surgical complication, yet, current risk prediction tools still suffer from poor predictive accuracy. We hypothesize that accuracy could be greatly improved by including dynamic postoperative vital sign data. This vital sign data is routinely collected during inpatient stays but some feasibility questions have been raised by our initial needs assessment. We are seeking Pilot funding to perform a developmental formative evaluation that will answer our questions. Using a mixed methods study design, first, we will evaluate the feasibility, acceptability, and potential usefulness of a decision support tool for use at hospital discharge. Second, we will examine the completeness of vital sign data and explore the potential biases of using incomplete national Corporate Data Warehouse vital sign data in our model. These results will inform a larger study to develop and test a prototype of our tool.